Biomechanical Optimization of Mitral Valve Repair Operations

PROJECT SUMMARY
Mitral valve disease is a significant cause of global morbidity and mortality. Evolving treatment guidelines support
earlier intervention and valve repair when possible. Advances in repair techniques have progressed in the clinical
arena primarily based upon anatomic and physiologic premises as well as surgeon experience. Yet, the
biomechanical engineering fundamentals and principles underlying mitral valve interventions are rarely
investigated. A more robust understanding of such principles and incorporation into surgical procedures may
enhance valve reparability and durability and thus ultimately translate into less thromboembolic and hemorrhagic
sequelae of long-term anticoagulation for mechanical valve replacement and less perioperative risks of
reintervention for bioprosthetic valve deterioration. We have designed and produced a novel 3D-printed heart
simulator into which mitral valve specimens can be mounted and studied throughout the cardiac cycle. Complex
disease states such as primary (degenerative) mitral regurgitation can be reproduced, allowing the investigation
of the biomechanical characteristics of various repair operations and novel devices. Innovative biomechanical
sensors within this simulator and state-of-the-art imaging modalities facilitate the detailed analysis of the
engineering principles behind these operations. We propose to study primary mitral valve regurgitation and
engineer novel minimally invasive devices and platforms to improve the treatment of this disease. We will then
validate these findings and devices in pre-clinical large animal models. We are optimistic that the proposed
experiments and devices will yield important knowledge on current and potential future clinical therapies for mitral
valve disease and can be rapidly translated to intraoperative patient care.

Public health relevance
PROJECT NARRATIVE Mitral regurgitation is a leading cause of morbidity and mortality worldwide, representing a major health crisis. We aim to develop novel minimally invasive devices for primary mitral regurgitation by optimizing the biomechanical principles of mitral valve repair and testing these devices on a customized 3D-printed heart simulator. Following validation in large animal cardiac surgery models, we hope to eventually translate these innovations directly to human clinical practice.